Pathways Regulating Lung Transplant Tolerance

PROJECT SUMMARY / ABSTRACT
Lung transplantation, the only available therapy for many patients who suffer from end-stage pulmonary failure,
continues to be plagued by disappointing long-term survival rates. Our research suggests that the premature
demise of many transplanted lungs is in large part due to the use of immunosuppression that is not tailored
towards the unique immunological characteristics of this organ. Our work will identify cellular and molecular
pathways that can be targeted to prevent rejection and promote tolerance after lung transplantation. To
accomplish this goal, we will utilize clinically relevant mouse models of lung transplantation, relevant conditional
knockout strains and intravital imaging platforms to examine how local and peripheral immune pathways protect
lung grafts from destruction by recipient immune cells. Our three projects are entitled “Local and peripheral
mechanisms of T cell-mediated immune regulation after lung transplantation” (Project 1), “Early and late
inflammatory events controlling lung allograft homeostasis” (Project 2) and “Targeting and imaging of
inflammatory circuits in CLAD” (Project 3). The program project will be supported by a Microsurgery Core and
an Administrative Core. Our proposed experiments will yield new information that will result in the development
of lung-specific therapies that will improve outcomes for pulmonary transplant recipients.

Public health relevance
PROJECT NARRATIVE Long-term outcomes after lung transplantation remain disappointing. Although immune responses to transplanted lungs differ from those to other organs, immunosuppressive strategies for lung transplant patients are similar to those after transplantation of other solid organs. It is of critical importance to develop immunosuppression that is tailored for lung transplant patients. To accomplish this goal, mechanisms that promote the survival versus rejection of transplanted lungs need to be studied in clinically relevant mouse models of pulmonary transplantation. In this proposal we will investigate lung-specific immune pathways that can be targeted to improve outcomes after pulmonary transplantation.